Investigating the sequelae of pulmonary tuberculosis in Gambian children and adolescents

As of 2023, there were over 9 million pediatric TB survivors globally. Many of these children often face
severe long-term respiratory impairments, including post-TB lung disease (PTLD). This condition arises
due to the damage TB inflicts on the developing lungs during critical growth periods, leading to
persistent respiratory deficits that significantly affect quality of life and productivity. However, the natural
history of PTLD and its predictors remain poorly understood, particularly in pediatric populations in
resource-limited settings where access to spirometry and other diagnostic tools is limited. The PI, Dr.
Esin Nkereuwem, proposes an innovative approach to address these critical knowledge gaps by
leveraging a well-characterized longitudinal cohort of pediatric TB survivors in The Gambia. This K43
project aims to integrate advanced longitudinal data analysis and cutting-edge artificial intelligence (AI)-
powered radiological tools to improve the diagnosis and monitoring of PTLD in resource-constrained
settings. Specifically, this study will address three aims: (1) to characterize respiratory health
trajectories in pediatric TB survivors using repeated spirometry, chest X-rays, and quality-of-life
assessments; (2) to identify host, environmental, and treatment-related predictors of long-term
respiratory impairment and develop a predictive risk model for stratifying children based on their risk of
adverse outcomes; and (3) to refine and validate an AI tool for detecting PTLD-specific radiological
abnormalities and assessing longitudinal changes in lung health. The project will leverage an
established infrastructure at the Medical Research Council Unit The Gambia, where Dr. Nkereuwem
has conducted previous research with high participant retention and rigorous data collection. Building
on preliminary findings showing significant respiratory impairments in pediatric TB survivors, the study
will generate longitudinal data to better understand recovery patterns and predictors of poor outcomes.
The AI tool will be refined and validated for pediatric use, offering a scalable alternative to spirometry
in resource-limited settings. These innovations will contribute to developing evidence-based guidelines
for the care and monitoring of pediatric TB survivors globally. This K43 Award will provide Dr.
Nkereuwem with advanced training in longitudinal cohort analysis, predictive modeling, and AI-based
radiological diagnostics under the mentorship of a multidisciplinary team of internationally recognized
experts in pediatric TB, AI diagnostics, and global health. Through structured mentorship, workshops,
and hands-on research, Dr. Nkereuwem will gain the skills necessary to establish an independent
research program focused on improving respiratory outcomes in children. This training and research
will ensure Dr. Nkereuwem’s contributions to the field are sustainable and impactful, aligning with the
mission of the Fogarty International Center to address pressing global health challenges in LMICs.

Public health relevance
The increasing global number of pediatric tuberculosis (TB) survivors underscores the urgent need for innovative diagnostic and monitoring tools to address post-TB lung disease (PTLD). This project aims to refine and validate artificial intelligence (AI)-powered radiological scoring tools and integrate them with longitudinal cohort data to characterize respiratory health trajectories, identify predictors of long-term impairment, and improve clinical care strategies for pediatric TB survivors. This research will help advance global health by addressing critical gaps in pediatric post-TB care as well as provide advanced training to Dr. Esin Nkereuwem, equipping him with the expertise and tools necessary to develop an independently funded research program focused on pediatric TB and respiratory health in Africa.